Research Training Program in Pediatric Exposomics

Project Summary
The Developmental Origins of Health and Disease (DOHaD) theory posits that early-life environment
contributes to nearly all common pediatric diseases (asthma, learning disorders, birth defects, obesity) and to
diseases in adult life. Recently the nascent field of “exposomics” -the study of all health relevant environment
across the lifespan has also taken hold, with new research initiatives such as the NIH Environmental influences
on Child Health Outcomes (ECHO) program and the Human Health Exposure Analysis Resource (HHEAR)
program. Multiple IOM reports state that there is a national need to expand research to address environmental
medicine issues, and new NIH initiatives (HHEAR and ECHO) have emphasized that children's environmental
health is a research priority. There is a clear need for scientists trained in the principles and methodologies of
exposomics who can then translate research into environmental pediatrics. To address that need, the Mount
Sinai School of Medicine seeks both to renew its 2-3 year transdisciplinary, post-doctoral research training
program in environmental pediatrics that began in 2007 and to expand its scope to Exposomics, the study of all
health relevant environment. Two fellows are admitted per year. Focus is on training in epidemiology,
biostatistics, data science, lab assays, geospatial statistics, environmental medicine and of course, child health
and development. An MS or MPH degree in epidemiology is available as well. Our program excels in mentored
research that produces publications, meeting presentations/posters, NIH K awards and fosters transition
toward independent research. Our fellows develop a methodological base in child development and exposure
science principles giving them a versatile set of skills and resources that they can apply to study a wide range
of scientific questions. Each fellow is guided by an interdisciplinary mentoring team. Courses and experiential
training are provided in grant writing, ethics and responsible conduct of research. Supervised clinical
experience in environmental pediatrics ensures that research training is grounded in clinical translational
principles. Formal evaluation of fellows is conducted semi-annually. An Executive Faculty Committee and an
External Advisory Board are in place. Our program builds on a unique base of NIH funded children's
environmental health research, including 2 HHEAR Lab Hubs, the HHEAR Data Center, 2 ECHO cohorts, a
P30 Core Center grant, multiple child health research cohorts, a Pediatric Environmental Health Specialty Unit,
and a unique Exposome Lab that specializes in exposure biomarkers. In its first 14 years, our program has
successfully recruited 30 fellows and graduated 24 (6 are still in training) of whom 14 have academic faculty
positions; 2 are doing additional research training fellowships, and the remaining 8 are in industry or
government. Seven have secured NIH funding; 4 in the last 5 years. Graduates are faculty at UC-Davis,
Columbia, NYU, U Minnesota, U of Cincinnati, Mount Sinai, work at the CDC and for Industry, have published
>400 papers and are now leaders in the nascent field of pediatric exposomics.

Public health relevance
Project Narrative Exposomics is a new field that aims to comprehensively study all health relevant environment and is a key tool to understand the developmental origins of health and disease. This research training program provides cutting edge post-doctoral research fellowship training in pediatric exposomics to prepare these early career researchers to become future academic leaders in the emerging field of environmental pediatrics.